Synthesis of Bioactive Natural Products

DESCRIPTION (provided by applicant): This research program (GM-29028), now in the twenty-seventh year, embodies the evolution of our long- standing commitment to: (A) enantioselective total synthesis of architecturally challenging, pharmacologically important natural products, (B) development and application of new, innovative synthetic methods, and (C) delivery of select targets and analogues in sufficient quantities (ca. 1 gram) for detailed biological evaluation. Going forward, the major thrust of 28-31 year program will be to define, at a fundamental level, the exciting potential of Anion Relay Chemistry (ARC). To demonstrate the diverse chemotypes accessible employing the ARC tactic, we will also undertake several target-oriented syntheses. Thus the revised overall Specific Aims for this program now include: (1) Design, synthesize and validate new, structurally novel linchpins to expand the utility of the ARC tactic; (2) Develop a detailed mechanistic understanding of the ARC tactic, with particular focus on the precise timing and stereochemical outcome of [1,n]-Brook rearrangements to maximize ARC efficiency; (3) Devise and explore an alternate route into the ARC reaction manifold; and most significantly, (4) Demonstrate the power of Iterative ARC (I-ARC) tactics (cf. living polymerization) for complex molecule synthesis (vide infra). To showcase the ARC tactic, we will: (5) Complete the total synthesis of (+) spirastrellolide B, an extremely potent marine antitumor macrolide; (6) Construct a small library of curvularin family members; and (7) Achieve effective total syntheses of secu'amamine A and EBC-23, an alkaloid and terpene respectively, representing two additional chemotypes that demonstrate the utility of the step-efficient ARC tactic.

Public health relevance
The principal goal of this research program comprises the design and application of new, innovative synthetic methods, in conjunction with the development of effective synthetic strategies to synthesize architecturally complex natural and natural product like compounds possessing significant bio-regulatory properties that serve as lead compounds for the discovery of new medicines.